Laboratory Sciences Core

Laboratory Sciences
In this 4th renewal application of the Miami CFAR, Drs. Savita Pahwa as Director and Sion Williams as Co- Director of the Laboratory Sciences Core (Core D) propose a centralized resource for immunology, genomics and virology with opportunities to stimulate novel HIV/AIDS research towards notable benchmarks of success. Since its inception, the goal of the Miami CFAR has been to evolve to keep pace with the changing needs of the epidemic to address important questions in HIV/AIDS. Accordingly, Core D’s strategy has been to maximize Core resources by leveraging institutional and external resources in order to be at the forefront of HIV/AIDS research. In the current cycle (2017-2022), Core D has made tremendous progress, energized by new projects, new technologies and new equipment. We remain cognizant of expectations from the users through periodic needs assessment exercises, adequate Core utilization to support for projects of our funded research base (FRB) and pilot awardees, mentorship to students and junior faculty, support research presentations at conferences and establish linkages with other CFARs to maximize our capabilities for alignment with NIH research priorities and advances in the field. For the next funding cycle, our goal is to provide needed services to our investigator base while ensuring access to state-of-the-art technologies that drive innovation and help to address key scientific questions in HIV/AIDS. Our specific Aims are: Aim 1. Serve as a one stop shop, that allows investigators to easily access Immunology, Virology and Genomics services to meet both needs for high demand assays as well as specialized assays that require dedicated expertise. Aim 2. Provide consultation, training and technical assistance for investigators at all levels (from undergraduate students to established investigators) to meet their needs for study design, generation of preliminary data and data for publications, and to disseminate information about scientific advances in the field through special lectures and workshops in collaboration with the Sylvester Cancer Center, Clinical and Translational Science Institute (CTSI) , and Departments of Microbiology and Immunology, and Infectious Diseases Division at the University of Miami (UM). Aim 3. Promote synergies in UM and provide research support/collaborations across Florida, NIH funded Networks and Programs by: a) Interaction with Cores, Scientific Areas of Interest (SIG), Scientific Working Groups (SWG) and CFAR membership at large, through participation in group discussions/meetings, collaborative research projects with clinical/biomedical science investigators; b) Advancing the CFAR laboratory expertise through leveraging non-CFAR resources and inter-CFAR interactions, and c) Responding to emergent institutional and societal research priorities for laboratory support, and to develop techniques to promote HIV research in commorbidities as they affect HIV; d) Offer CFAR expertise to support HIV Network activities and HIV research outside UM. Aim 4. Develop and abide by policies and procedures for the Core in compliance with Core A directives and guidance.